Reducing Racial and Ethnic Disparities in Medicare Annual Wellness Visit Uptake

ABSTRACT
Older adults from historically socially excluded groups such as racial and ethnic minorities face health
inequities in the form of disproportionately high burdens of illness and mortality. Research has also shown
lower preventive service uptake and lower self-rated health in socially excluded groups of older adults.
Medicare Annual Wellness Visits (AWVs) are a promising tool to address these disparities. AWVs are
Medicare’s form of the checkup visit, and have been available to Medicare enrollees, with zero copay, since
2011. A recent review by our team demonstrated that checkups in adult primary care improve clinical
preventive services completion and patient-reported outcomes. Checkups also reduced mortality in two of four
randomized trials in older adults. Despite the potentially dramatic benefits of checkups in older adults,
published research and data from our health system have shown lower AWV completion in older adults who
are Black or Latino/Hispanic, compared with Whites. Also, little is known about how to maximize AWV
completion in socially excluded groups. Though early studies have identified some patient-level barriers to
AWV completion, no high-quality, controlled studies have prospectively evaluated an intervention to increase
AWV completion, and none have targeted racial/ethnic minority populations. However, since most AWV
appointments are initiated by practices or health systems and AWVs are delivered by primary care teams,
interventions to address disparities in AWVs must incorporate input from both patients and clinical
stakeholders. We hypothesize that a targeted, community-engaged approach to intervention development can
increase AWV completion in older Black and Latino/Hispanic patients and, in turn, improve their quality of care
and patient-reported outcomes. Our first specific aim is to develop and refine an intervention to reduce
racial/ethnic disparities in Medicare AWV completion. We will conduct focus groups on perceptions and
barriers to AWVs among English- and Spanish-speaking patients in academically affiliated and safety net
primary care practices. Then, a multi-stakeholder Community Advisory Board will collaborate with our health
system to design and implement an AWV intervention across the continuum of pre-visit, in-office, and post-visit
settings. In our second specific aim, we will conduct a pilot trial at two community-based primary care
practices, in preparation for an eventual full-scale effectiveness trial. We will randomize six physician
volunteers, and deliver the intervention to 90 patients. The primary outcome will be Medicare AWV completion.
Secondary outcomes include preventive services completion, self-rated health, and health-related quality of
life. At the conclusion of the pilot trial, care teams that implemented the intervention will inform future work by
providing feedback about the intervention, training, and implementation strategies. This project aligns with
National Institute on Aging priorities to develop strategies to improve the health status of older adults in diverse
populations (Goal F), and can produce generalizable findings on how to advance health equity in older adults.

Public health relevance
PROJECT NARRATIVE Checkup visits, such as the Medicare Annual Wellness Visit, can increase older adults’ use of preventive care, improve patient-reported outcomes, and reduce mortality. Older adults from historically socially excluded groups such as racial and ethnic minorities often have low preventive care use and low self-rated health, and complete Annual Wellness Visits at very low rates. This project will use community-engaged approaches to develop and pilot test an intervention to increase Annual Wellness Visit completion in older Black and Latino/Hispanic adults.